Contribution of child development, biological aging, and beta-amyloid to cognitive function of the Louisville twins at midlife

Project Summary/Abstract
The proposed study will clarify whether accelerated biological aging at midlife predicts higher levels of
preclinical AD biomarkers, as measured using a highly reliable plasma beta-amyloid (Aβ) marker. We will
study 750 individual twins age 40-64 from the Louisville Twin Study (LTS) to test the hypothesis that
accelerated aging contributes to Aβ accumulation and changes in cognitive functioning in midlife. We will locate
and recruit the twins, conduct in-person cognitive functioning and physical assessments at the University of
Louisville, and collect 50cc of blood from each twin to quantify biological age, plasma-Aβ, and to genotype
them. Our ability to recruit twins to participate for a new phase of study is demonstrated in our 2018 Midlife
Pilot Study, in which we collected cognitive ability, physical measurements, and blood to construct a biological
aging measure. Preliminary results suggest that biological age is a better predictor of episodic memory than
global functioning, consistent with prior research. The LTS is the only twin study capable of linking accelerated
aging, Aβ accumulation, and cognitive functioning at midlife to cognitive functioning in early life, as other
comparable longitudinal twin study samples are currently too young. We will address two research questions:
1) Do individuals with genetic and environmental predispositions for accelerated aging have greater Aβ
accumulation and perform worse cognitively in midlife?; and 2) How do early life developmental characteristics
influence biological aging, Aβ, and midlife cognitive functioning? To address these questions, we will complete
the following specific aims: Quantify several markers of biological aging to test whether accelerated aging
predicts Aβ accumulation and lower cognitive functioning at midlife by collecting biological, cognitive, memory,
and functional ability data from LTS twins age 40-64 (Aim 1); Determine whether Aβ accumulation mediates
effects of accelerated aging on diminished cognitive functioning, adjusting for confounding genetic and
environmental factors (Aim 2); Evaluate effects of early life characteristics on accelerated aging, Aβ
accumulation, and cognitive functioning in midlife, adjusting for confounding genetic and environmental factors
(Aim 3). The proposed research is significant because it will specify causal effects of accelerated aging in
midlife on Aβ accumulation and cognitive functioning, using blood-based aging measures to predict Aβ
accumulation, and will investigate causal effects of early life developmental mechanisms on accelerated aging,
Aβ accumulation, and cognitive functioning at midlife. The proposed work is innovative because of the novel
application of a lifespan twin study, the capability of strengthening causal conclusions about the effects of
accelerated aging on AD biomarkers in midlife when randomization is impossible; and because it will establish
new standards for plasma-Aβ data collection in longitudinal twin studies. Consistent with NIA’s aims, this
project will test the clinical utility of accelerated aging measures as early indicators of ADRD risk.

Public health relevance
PROJECT NARRATIVE The biological determinants of Alzheimer’s disease and related dementias (ADRD) are established decades before clinical symptoms of cognitive decline, memory loss and functional decline are observed. As age is the most reliable predictor of ADRD, the proposed study will test whether biological age, as opposed to chronological age, predicts higher levels of preclinical AD biomarkers, as measured with a highly reliable plasma beta-amyloid (Aβ) marker, and whether Aβ accumulation contributes to cognitive decline in midlife in a well-established longitudinal twin sample, the Louisville Twin Study. The nature of this twin design will inform causal pathways between early life development, biological age, Aβ, and cognitive functioning at midlife, shedding light on genetic and environmental mechanisms that promote risk and resilience of preclinical AD.